Diversity Supplement to Urban Greenness and Cardiovascular Health

Abstract
Extensive research suggests that components of the natural environment have profound effects
on human health. In particular, individuals living in areas of low pollution and high levels of
vegetation have been reported to have a lower burden of cardiovascular disease (CVD). Although
many studies have shown that exposure to air pollution increases CVD risk and mortality, the
impact of greenspaces and vegetation on CVD has not been directly studied. Hence to assess
the impact of greenery on cardiovascular health and disease risk, we will conduct a pragmatic,
interventional trial designed to test the hypothesis that exposure to neighborhood greenspaces
diminishes CVD risk by decreasing the levels of local air pollution. To test this hypothesis, we will
first evaluate baseline cardiovascular health in 16 residential neighborhood clusters with sparse
greenspaces (Aim 1). In these areas, we will measure the levels of greenery, air pollution, noise
and traffic, and determine how these neighborhood characteristics are associated with hospital
admissions, as well as cardiovascular and all-cause mortality. To acquire individual level data,
we will recruit 700 area residents and assess their cardiovascular health as well as psychosocial
stress. Then, in 8 “target” clusters, we will plant nearly 8,000 established trees (Aim 2). There will
be no deliberate change in greenspace in the 8 “control” clusters. Following the greening
intervention, we will determine how an increase in greenspaces within the target clusters affects
air pollution levels, hospital admissions and mortality, and how the greening intervention affects
CVD risk and psychosocial stress within this community in comparison with the control area (Aim
3). Completion of this project would provide a new understanding of the link between urban
greenspaces and cardiovascular health, and might lead to the development of new strategies to
prevent CVD and to decrease the levels of urban air pollution. Importantly, the results of the
project will lead to the development of a comprehensive model that could be readily adopted by
cities throughout the world to create urban environments that are more conducive to human
health.

Public health relevance
LAY SUMMARY This project is to determine how an increase in urban greenspaces affects cardiovascular disease risk, severity and mortality. To assess the impact of greenspaces, we will examine how an increase in neighborhood greenspaces affects the levels of air pollution and cardiovascular health in an urban community.